Targeting Endoplasmic Reticulum Stress Sensor IRE1 to Enhance Chemotherapy Sensitivity in MYC-driven breast cancer

ABSTRACT
Limited sensitivity to chemotherapy and an immunosuppressive tumor microenvironment drives breast cancer
mortality in HER2 negative breast cancer. We have identified the IRE1/XBP1 branch of the Unfolded Protein
Response (UPR) or endoplasmic reticulum (EnR) stress response as a previously unexplored therapeutic
vulnerability in MYC-driven breast cancer that enhances chemotherapy sensitivity and reverses the
immunosuppressive tumor microenvironment. IRE1 is amplified in ~10% of human breast cancer, and
frequently co-amplified with the MYC oncogene. Activation of MYC is synthetic lethal with IRE1/XBP1 pathway
inhibition. We found that inhibition of the IRE1/XBP1 pathway with a highly selective first-in-class IRE1 RNase
inhibitor ORIN1001 suppresses MYC-high-expressing (MYChigh), but not MYC-low-expressing (MYClow), tumor
growth in patient-derived xenograft (PDX) models. ORIN1001 substantially enhances the docetaxel efficacy,
resulting in rapid tumor regression and complete eradication of the MYChigh PDX tumors. Furthermore, the
ORIN1001 plus docetaxel therapy triggers massive cytotoxic T-cell infiltration, depletion of immunosuppressive
myeloid-derived suppressor cells (MDSCs) and substantial upregulation of PD-L1 in the tumor
microenvironment. Non-human primate toxicology testing showed that ORIN1001 has excellent safety profile
and is well-tolerated. These preclinical data prompt us to hypothesize that inhibition of the IRE1/XBP1 pathway
with the IRE1 inhibitor ORIN1001 compromises MYChigh breast cancers by inhibiting obligatory UPR stress
adaptation required for cellular viability. This therapeutic effect of ORIN1001 is associated with a marked
increase in taxane sensitivity. In addition, MDSCs are also selectively depleted by ORIN1001 in the presence
of a taxane, thus reversing immunosuppression and potentially sensitizing MYChigh breast cancers to immune
checkpoint intervention. A pre-clinical phase study in breast cancer models will be conducted in parallel with a
Phase 1 clinical trial. In Aim 1, we will establish diagnostic tests to determine eligibility for a clinical trial of
ORIN1001 plus taxane combination therapy. Aim 2 will exploit the immunomodulatory effects of ORIN1001
plus docetaxel therapy in breast cancer by testing the addition of anti-PD-L1 immunotherapy. In Aim 3, we will
conduct a phase I dose escalation study of ORIN1001 alone, then in combination with paclitaxel, followed by
expansion cohorts in 4 subsets of breast cancer. The overarching objective of this proposal is to design and
open a Phase 2 clinical trial in MYC-positive metastatic breast cancer with eligibility and endpoints to be
defined by the execution of the research aims.

Public health relevance
NARRATIVE After the introduction of successful HER2 directed therapeutics, most fatal cases of breast cancer are associated with chemotherapy-insensitive triple-negative or luminal B breast cancer. Our research will establish endoplasmic reticulum stress sensor IRE1-targeted therapy as a novel therapeutic approach to enhance chemotherapy sensitivity and reverse the immunosuppressive microenvironment in the presence of chemotherapy that sensitizes MYC-driven breast cancers to immune checkpoint intervention.